IAFF Hazmat Training (HWWT)

HWWT Program Summary Abstract
Under the Hazardous Waste Worker Training Program (HWWT), the International Association of
Fire Fighters (IAFF) addresses significant concerns related to hazardous materials incidents and
emergency response through specialized training programs and enhances the skills and
knowledge of first responders handling and responding to hazardous materials incidents.
Objectives: The IAFF proposes to continue its first responder health and safety training program
under HWWT to enhance firefighter safety by providing essential training for managing and
mitigating hazardous materials incidents, as well as addressing emerging health and safety
challenges faced by hazardous materials responders and emergency response personnel.
Specific Aim 1: Enhance the capabilities of emergency responders by delivering current or updated
firefighter safety and health training programs. Specific Aim 2: Identify specific first responder
organizations and communities at risk of encountering or being affected by HazMat incidents.
Specific Aim 3. Maintain evaluation protocols to gauge training effectiveness and ensure the
program meets and exceeds the NIEHS Minimum Training Criteria Document.
The IAFF targets firefighters, emergency medical workers, disaster relief workers, public health
workers, and law enforcement under the HWWT program. Annually, the IAFF will conduct six
HazMat Technician classes and six Confined Space Rescue classes and train 300 students. Over the
five-year grant period, 60 classes will be delivered to 1,500 students. This training effort addresses
the needs of emergency responders in both urban and rural areas across the United States and
addresses emerging threats to include training on the latest hazards, such as renewable energy
sources and energy storage systems.
The benefits include a reduced risk of accidents and health issues associated with hazardous
material exposure; Improved public health by minimizing hazardous material-related injuries and
deaths; Highly trained emergency responders who can effectively respond to emergencies and
protect communities.